TB Research And Mentorship Program (TB RAMP)

Summary/Abstract:
The TB Research And Mentorship Program (TB RAMP) prepares early-stage investigators (post-doctoral
fellows, clinical fellows, junior faculty) from University of California, San Francisco (UCSF) and UC Berkeley for
successful careers in tuberculosis (TB) research. Through this research education program focused on TB, we
promote and catalyze collaborations between existing faculty across disciplines (infectious diseases, pulmonary
medicine, experimental medicine, systems biology, genomics, immunology, health economics, pharmacy,
nursing, implementation sciences, diplomacy and policy, global health, etc.); attract and cultivate scholars and
junior investigators in the TB field; and strengthen TB research expertise regionally and globally. TB RAMP
leverages the extensive NIH-funded training resources at UCSF to have a significant and lasting impact on the
conduct of global TB research, as well as on innovations in TB discovery, care and control. Specific Aim 1: The
TB Science Intensive. A two-week TB Science Intensive (TBSI) curriculum will be developed and delivered
annually to TB RAMP scholars to provide the core concepts and methodologies of TB research and includes
skill building in TB RAMP scholars’ own interests and research methods area. The TBSI is enhanced through
delivering content expertise to address TB scientific knowledge gaps and to allow TB RAMP scholars to develop
their own research protocols for subsequent grants. Specific Aim 2: Research Experiences and Awards
Program (REAP). Match scholars with research opportunities through existing transdisciplinary network of
research mentors, faculty, and sites, and support innovative research projects linked to peer-reviewed awards.
Identified program faculty with extensive research experience and opportunities will be paired with scholars
interested in TB research. Research infrastructure at UCSF spans genomics laboratories to state public health
departments. Faculty also have collaborations in high burden settings across Asia, Africa, and the Americas that
will provide TB RAMP scholars access to data, biospecimens, and opportunities to network with faculty from
sites in high-burden settings. Scholars will compete for intramural, peer-reviewed seed funding opportunities.
The goal of the REAP is to provide TB research experiences that expand or extend the existing skills of scholars,
to provide opportunity for meaningful contribution to research related to the NIAID mission, directly addressing
the NIAID Strategic Plan for TB Research. Specific Aim 3: Mentoring Activities. Provide structured, high-
quality, sustained mentoring for all scholars enrolled in the program, differentiated into two tracks to provide
personalization and specialization; Track 1: Basic and Translational Science and Track 2: Clinical and
Operational Science. Creating and nurturing a strong set of mentoring relationships is essential to both core
components of TB RAMP, as is developing a rich set of research networks that can support TB RAMP scholars
throughout their careers. TB RAMP scholars will have the opportunity for additional mentoring from our
international partnered PIs via remote communication.

Public health relevance
Public Health Relevance Statement: Tuberculosis (TB) is now the leading infectious disease threat in the world, killing more people than HIV/AIDS, as reported today by the World Health Organization. The TB RAMP program at UCSF is a collaboration between the School of Medicine, Institute for Global Health Sciences, and Curry International TB Center all of UCSF; the UC Berkeley School of Public Health; and the Center for Infectious Diseases in the California Department of Public Health. The program seeks to catalyze the development of research scientists focused on TB and on addressing the NIAID Strategic Plan for TB Research. This program is committed to developing scholars at the early stage of their careers by offering innovative training on TB disease, access to research opportunities, provision of sustained mentorship, and support for pilot projects to launch their research careers. TB RAMP scholars will be inspired, well trained, and mentored to pursue high quality and innovative research focused on combatting the TB epidemic.